DIAZEPAM AND BUSPIRONE IN LIGHT AND SOCIAL DRINKERS

The purpose of this protocol is to investigate and compare the reinforcing effects of the anxiolytic drugs diazepam (Valium) and buspirone (Buspar) in moderate drinkers. Buspirone is a recently marketed non benzodiazepine anxiolytic which is purported to have lower potential for abuse and 14ess sedative effect than benzodiazepine axiolytics such as diazepam. Our hypotheses are: 1. that diazepam will be significantly preferred to placebo; and 2. that buspirone will not be significantly preferred to placebo.